Inflammatory mechanisms of dysbiosis in laryngeal glottic stenosis

PROJECT SUMMARY
Acute laryngeal injury (ALgI) occurs in over 50% of patients after intubation and mechanical ventilation.
ALgI is associated with significantly worse voice, breathing, and swallowing months after extubation. ALgI
results from endotracheal tube pressure on the posterior glottis, leading to ischemic mucosal injury that
progresses to glottic scar and debilitating phonatory insufficiency or life-threatening narrowing of the glottic
airway. Glottic stenosis is managed with tracheostomy or destructive surgery sacrificing vocal quality for airway
patency.
There is a critical need for focused scientific approaches to identify key elements of pathologic wound
healing following intubation-related laryngeal injury for the development of novel precision therapeutics.
Studies of patients with post-intubation tracheal stenosis have implicated impaired epithelial barrier function,
which leads to microbial infiltration into the tissue lamina propria, dysregulated adaptive immunity, and
pathologic T-cell-fibroblast interactions that drive excessive extracellular matrix production. However, glottic
stenosis is different, with severe functional implications of even minor scarring of the unique glottic anatomy.
There is a significant knowledge gap regarding the pathophysiology of intubation-related glottic injury, and
therefore a lack of evidence-based approaches to optimize wound healing to prevent scar.
The PI has identified clinical bacterial culture positivity in 75% of human ALgI specimens, with Staph
aureus most commonly isolated.1Persistent antigenic stimulation, such as in chronic infection, is known to
induce sustained immune cell activation. The PI has measured increased T-cell infiltration and activation in
patients with post-intubation tracheal stenosis, however the T-cell response following glottic injury is poorly
characterized. Dysbiosis (imbalanced microbial composition) and its impact on the immune response have
been linked to the progression of pulmonary fibrosis, however, a relationship among dysbiosis, immune
activation and fibrosis has not been evaluated in glottic scar.
In this study, we will determine the effect of dysbiosis-mediated immune activation on glottic scar
formation in humans (Aim 1) and a novel murine model (Aims 2-3). In Aim 1 we will employ single-cell RNA
sequencing and 16S rRNA sequencing to determine the impact of dysbiosis and immune activation on the
formation of glottic scar in patients following laryngeal injury. In Aim 2, we will establish the role of microbiome-
induced immune activation in the development of glottic scar by comparing laryngeal wound healing in germ-
free and conventionally raised mice. Finally, in Aim 3 we will evaluate the impact of pathogenic bacteria and
therapeutic microbiome modulation on the formation of glottic scar using the gnotobiotic mouse model.

Public health relevance
PROJECT NARRATIVE The research proposed in this application will investigate the role of dysbiosis-mediated immune activation in glottic wound healing following intubation injury, using human samples and a novel mouse model. This proposal also investigates microbiome modulation as an innovative approach to reduce chronic immune activation and prevent glottic scar.